Targeting alloantigen presentation in bone marrow to enhance graft-versus-leukemia effects

ABSTRACT
Blood cancers account for approximately 10% of all malignancies and allogeneic bone marrow transplantation
(BMT) is a preferred curative therapy for these serious conditions. While the therapeutic potential of this
procedure lies in graft-versus-leukemia (GVL) effects in which donor T and NK cells eradicate host malignancy,
BMT outcomes are limited by transplant-related complications, mainly graft-versus-host disease (GVHD) in
which donor T cells attack host normal tissues and opportunistic infections. Indeed, 15-20% of BMT patients
develop severe GVHD that is fatal, particularly when involving the gastrointestinal tract, however, relapse of the
primary malignancy is still high and eventually responsible for the majority (40-60%) of transplant failures and
death. Current prevention and treatment of GVHD which rely on the broad suppression of T cells abate GVL
effects. Thus, the immunological intervention to minimize GVHD with promoting GVL is unmet need in BMT. The
initiation and maintenance of donor T cell responses are dependent on alloantigen presentation by antigen-
presenting cells (APC). Although recently the types of APC that induce and enhance GVHD and the
immunological mechanisms therein have been elucidated, their role in GVL and the presence of GVL-specific
APC remain unknown. In this proposal, we focus on GVL-requiring APC to enhance GVL and precent leukemia
relapse. In particular, we will build on our preliminary data to test the hypothesis that donor T cells primed at
extramedullary sites migrate into the BM where their anti-leukemic capacity is maintained via alloantigen
presentation by recipient stromal APC. We will utilize cutting-edge mechanistic preclinical murine studies, using
advanced flow cytometry, multiplexed immunofluorescence microscopy, RNASeq, and REAP/CITE-seq, to
understand antigen presentation required for effective GVL and relapse prevention. Finally, we will test a novel
attenuated synthetic IL-18 resistant to the IL-18 binding protein (decoy resistant (DR-18)) that has been fused to
CXCR4 nanobody or CD117 antibody to selectively enhance IFNg and antigen presentation locally in the bone
marrow. The proposal will lead to a new, clinically tractable approach to selectively promote GVL and prevent
relapse after allogeneic BMT.

Public health relevance
PROJECT NARRATIVE Blood cancers account for approximately 10% of all malignancies and allogeneic bone marrow transplantation (BMT) is a preferred curative therapy due to the graft-versus-leukemia (GVL) effects, in which donor T and NK cells eradicate host malignancy. Although recently, the types of APC that induce and enhance GVHD have been elucidated, the presence and nature of GVL-specific APC remain unknown. In this proposal, we will focus on identifying GVL-dependent APC in order to generate new therapeutic approaches to enhance GVL within bone marrow that do not exacerbate GVHD.